Integrative genomic analysis of adenosine-to-inosine editing in Alzheimer's disease

PROJECT SUMMARY
Post-transcriptional modifications by adenosine-to-inosine (A-to-I) RNA editing are a major contributor to the
global diversity of RNA sequences in the human brain. A-to-I editing occurs either at an isolated adenosine
(‘selective editing’) or across many neighboring adenosines in an extended region on the same transcript (‘hyper-
editing’). These base-specific alterations occur across most neuronal and non-neuronal expressed genes, and
are required for normal brain function. A-to-I editing has been shown to influence alternative splicing, recode
amino acid sequences of proteins, alter the ability of miRNAs to bind to their target sites, and change the stability
of RNA secondary structures. Moreover, recent work show that these modifications are tightly regulated in the
brain, and changes in editing levels are tied to etiology of neurodevelopmental and neurodegenerative disorders,
including Alzheimer’s disease (AD). Nevertheless, major gaps exist in understanding the neuropathological roles
of A-to-I editing in the AD brain. The vast majority of sites are likely to be dynamically regulated among different
cell types, brain regions in AD and across dementia severity. Yet, the status quo as it pertains to such context-
dependent regulation of RNA editing can be summarized as little or none. Moreover, while most efforts have
studied individual selective A-to-I editing sites independently, there is a complete dearth of research on the role
of A-to-I hyper-editing and hyper-edited genes in AD, which have profound effects on transcriptional and
translational regulation. Finally, while existing studies on the regulation of RNA editing mainly focused on the
adenosine deaminase acting on RNA enzymes, the role of cis-acting genetic regulation (editing quantitative trait
loci [edQTLs]) has been understudied and underpowered. This proposal will capitalize on the success of large-
scale genomics and consortia efforts to elucidate functional and highly regulated RNA editing sites in normal
aging and AD at a previously impossible scale. The current proposal is designed to overcome current knowledge
gaps by: Aim 1) Addressing the unmet need for basic neuroscientific research that can capture fundamental
regulation of RNA editing across multiple brain regions and cell types in normal aging and AD; Aim 2) Integrating
individual genetic information from large cohorts to build powerful edQTL maps and uncover credible sets of AD
risk loci that exert their pathogenic effects by changing RNA editing levels in the brain; Aim 3) Applying data-
driven computational methods to annotate and prioritize functionally important RNA editing sites and hyper-
edited genes strongly linked to AD, thereby advancing our understanding of the complex etiology of AD through
the lens of RNA modifications. Results from this proposal will generate a more complete picture of the molecular
and genetic landscape of AD, and will advance the identification of new therapeutic targets.

Public health relevance
PROJECT NARRATIVE RNA modifications by adenosine-to-inosine (A-to-I) editing are highly enriched and tightly regulated in the human brain, and their dysregulation has been implicated in the neuropathology of Alzheimer’s disease (AD). This proposal represents a critical step towards identifying functionally important editing sites and hyper-edited genes involved in normal aging and AD etiology, including those that are dynamically regulated across brain regions, discrete cell types, and those that are genetically regulated. Results from this proposal will serve as a valuable resource to expand neuropathological and genetic underpinnings of AD, offering a springboard for more effective therapeutic targets for this devastating disease.